Mount Sinai Clinician Scientist Training Program in Emergency Care Research

PROJECT SUMMARY
Emergency medicine lags behind other fields in the scope and depth of its research enterprise due, in part,
to a lack of well-trained investigators. To address this, the Icahn School of Medicine Department of Emergency
Medicine, ranked 4th in the U.S. in NIH funding, established the “Mount Sinai Clinician-Scientist Training
Program in Emergency Care Research” (ECR) to train clinician-scientists in emergency care research. Having
enrolled seven outstanding postdoctoral fellows thus far, this multidisciplinary program will now be expanded to
3 slots per year and will recruit doctoral-level applicants from health-related professions in addition to clinicians
trained in the specialties involved in ECR: emergency medicine, cardiology, pulmonary, critical care, & trauma
surgery. The overall aim of the program is to provide research-minded clinicians and health-related
professionals with a strong foundation in the principles of clinical / health services research and the mentored
research experiences necessary to: a) pursue independent careers in ECR; b) become valuable, contributing
members of multidisciplinary research teams; and c) accelerate dissemination of findings and rapidly translate
their research into clinical practice.
Led by Lynne D. Richardson, MD, an experienced investigator and successful mentor, the program partners
with Conduits – the Mount Sinai CTSA, the Center for Health Equity and Community-Engaged Research, and
the Center for Multicultural and Community Affairs, as well as colleagues in Medicine, Cardiology, Pulmonary
Medicine, Critical Care, Population Health Science & Policy, and collaborating research faculty from throughout
the institution to offer a well-rounded, collaborative research training experience. Fifty faculty members from 12
departments serve as potential research mentors or as translational or methodological advisors. Key program
components include: superb multidisciplinary mentorship, individual and collaborative research activities, formal
didactic instruction, and career and leadership development activities. Each fellow’s Individual Development Plan
includes completion of a Master’s degree in Clinical Research. Three new postdoctoral fellows will be enrolled
each year for 2-3 years of training. The program, program leadership, mentors, and fellows are evaluated
annually and the findings are used for program improvement. To increase the diversity of the research workforce
pipeline, this training grant incorporates a Short-Term Training Program in Health Disparities Research for
underrepresented minority/disadvantaged students to expose them to health disparities research in the
emergency care setting. Twelve Black and Latino predoctoral students were trained over the past two summers.

Public health relevance
PROJECT NARRATIVE U.S. Emergency Departments (ED) had approximately 145 million visits in 2016, a figure that has been steadily rising for the past twenty years.1,2,3 Twenty-five percent of the U.S. population visit the ED each year4, many of whom are the sickest and most vulnerable in the health care system,11 presenting with complex disease processes and high risks of adverse events. There is a specific need for emergency care clinicians and related health professionals to be trained as clinical and health services researchers to improve health outcomes and decrease preventable ED visits.